INDUCTION OF MUCOSAL IMMUNITY TO HIV IMMUNOGENS

The overall goal of this project is to develop mucosally targeted subunit vaccines that can elicit potent mucosal and systemic neutralizing antibodies and major histocompatibility compels (MHC) class I restricted cytotoxic T-lymphocyte (CTL) responses to human immunodeficiency virus type 1 (HIV-1) and HIV-1 infected cells. Specific aims are as follows: Specific Aim 1. We will test the chimeric HIV peptide T1-SP10MN(A) administered to the mucosal surface of rabbits via chronically isolated ileal loops (Thiry-Vella model) for induction of HIV-neutralizing secretary IgA (S-IgA) and IgG in vaginal and gastrointestinal secretions and in serum. Specific Aim 2. We will incorporate mucosal adjuvants and the HIV peptide T1-SP10MN (A) into biodegradable poly (DL-lactide-co-glycoside) (DL-PLG) microsphere, administer these parenterally and orally to Balb/mice, and evaluate mucosal anti-HIV-1 S-IgA, IgG and MHC class I- restricted CTL responses. Specific Aim 3. We will characterized the mucosal immune response to parental immunization with the T1-Sp10MN (A) peptide in normal subjects. Specific Aim 4. We will assess in rhesus monkeys a peptide/adjuvant/microsphere inoculum designed to optimize an anti-HIV envelope mucosal immune response. Specific Aim 5. To study the ability of IgA to neutralize HIV-1, we will produce IgA monoclonal antibodies to the V3 domain of HIV-1 MN gp120 and measure their ability to neutralize HIV-1 and enhance HIV-1 infection in the presence and absence of complement.